Regulation of hippocampal function by central and peripheral IRS signaling

Abstract
The insulin receptor substrate proteins Irs1 and Irs2 mediate insulin/IGF signaling (IIS) throughout the body—
including the brain—and mice that lack Irs1 and Irs2 develop insulin resistance and metabolic disease. While
substantial evidence exists that peripheral insulin resistance and type 2 diabetes (T2D) exacerbate age-related
cognitive decline and ADRD (Alzheimer’s Disease and Related Dementia), ascertaining causation by either
impaired central IIS or ‘metabolic sequelae’ of peripheral metabolic disease requires model systems that can
yield mechanistic insights. Above all, experimental systems are required that allow measurement of
parameters relevant to human cognitive impairment across a range of well-controlled conditions. Our approach
satisfies this imperative through routinized analyses of hippocampal function—including partially hippocampus-
dependent spatial learning in the Morris water maze (MWM) and neurogenesis in the dentate gyrus of the
hippocampus (DG). These assays are validated by our preliminary studies on mice lacking Irs2 in neurons
(nIrs2-/- mice), and extended in our approach to mice with unique central (neuronal) and peripheral (e.g.
pancreas or liver) expression of Irs1 and Irs2, plus down-stream Foxo1. We moreover analyze directly central
IIS mediated by Irs1 and Irs2 in the hippocampus, together with its possible feedback regulation by multi-site
serine/threonine phosphorylation of Irs1 and Irs2 (pS/TIrs). AIM1 tests the possibly unique roles of neuronal Irs1
and Irs2 to mediate central IIS—answering whether the benefits to hippocampal function of attenuated
neuronal IIS via Irs2 seen in nIrs2-/- mice owe to compensatory upregulation of neuronal IIS via Irs1. AIMs 2-3
focus on the mechanistic significance of metabolic sequela. Since high blood glucose and compensatory
insulin hypersecretion are prominent metabolic sequelae of T2D, AIM2 takes a novel approach to restore Irs2
expression in beta cells (reducing glucose) or liver (reducing glucose and insulin) in diabetic Irs2 knockout
mice. AIM3 exploits our established LDKO and LTKO mouse models—which lack hepatic Irs1 and Irs2
(diabetic) or Irs1 and Irs2, plus Foxo1 (non-diabetic). First, AIM 3 compares hippocampal function in LDKO vs
LTKO mice created acutely using viral Cre. Second, since our published work supports a role of hepatic FoxO1
and increased liver-secreted hepatokine follistatin (Fst) in propagating hepatic insulin resistance to other
tissues, AIM 3 employs viral methods to restore FoxO1 expression in LTKO mice, or to knock down expression
of Fst in LDKO mice, investigating in detail the effects on hippocampal function. How insulin resistance and
diabetes promote cognitive decline is an important clinical and research question. Together, the proposed
experiments can elucidate connections between metabolic disease and cognitive dysfunction by dissecting
roles of neuronal Irs1 and Irs2, and determining the specific influences of impaired peripheral insulin sensitivity
and associated metabolic sequelae upon hippocampal function.

Public health relevance
This proposal entitled `Regulation of hippocampal function by central and peripheral IRS signaling', brings our core focus on insulin receptor substrates to bear on the medically important problem of how insulin resistance and diabetes promote cognitive decline. Our proposal investigates the function of the insulin receptor substrates in the hippocampus and in peripheral tissues to regulate cognitive function in aged mice during progressive metabolic disease. Our approach employs mice with unique patterns of Irs1 and Irs2 expression to distinguish effects of neuronal versus peripheral insulin signaling. Our innovative experimental models can reveal new mechanistic insights that can guide development of targeted strategies to prevent cognitive decline during diabetes.